WNK Kinase Regulation of Thiazide-sensitive NaCl Transport

Project Summary
Salt transport by the kidney is dysregulated in many diseases, including heart failure and hypertension. This
project is designed understand how sodium chloride reabsorption along the distal nephron in the kidney is
regulated by diet and disease. The work will focus on the distal convoluted tubule and the thiazide-sensitive
NaCl cotransporter, which play key roles in regulating arterial pressure, systemic potassium balance, and the
development of resistance to diuretic drugs. The thiazide-sensitive NaCl cotransporter is activated by low NaCl
intake or low potassium intake through WNK kinases, which eventually affect its phosphorylation status. Low
potassium intake reduces intracellular chloride concentration, activating these kinases, but the kinases can also
be activated when intracellular chloride concentration is high. When stimulated, WNK kinases form condensates,
with other regulatory proteins. In the first aim, we will study two novel components of these WNK signaling
condensates, which activate the kinases under diverse conditions. We will determine whether the condensates
comprise localized regions of low chloride concentration, and also study how the novel proteins interact with a
kidney-specific form of WNK1 that is known to be essential for their formation. In a second aim, we will test the
hypothesis that signaling by G-protein-coupled receptors in this same nephron segment activates WNK kinases
and contributes to human disease. We showed recently that raising luminal calcium activates the thiazide-
sensitive NaCl transporter, through stimulation of the calcium-sensing receptor. We will therefore test whether
increases in luminal calcium caused by loop diuretic actions upstream contribute to distal convoluted tubule cell
growth and to diuretic resistance. We have shown that glucose or fructose can also activate the thiazide-sensitive
NaCl cotransporter via the calcium-sensing receptor in the distal convoluted tubule luminal membrane; we
believe that this effect may underlie some of the high blood pressure that results from diabetes or when
individuals consume fructose-containing beverages. Here, we will confirm the involvement of the calcium sensing
receptor, by deleting it genetically. We will also use novel approaches to mimic G protein-coupled receptor
stimulations exclusively in the distal convoluted tubule. Preliminary data shows that activation of the receptors
in the basolateral membrane rapidly reduces salt transport; here, we will test whether this effect is mediated
through inhibition of potassium channels in the basolateral membrane. Finally, we will determine whether
angiotensin II and low salt diet, long known to stimulate sodium chloride transporter activity, do so through
another G-protein-coupled receptor, the angiotensin receptor. Together, these experiments will provide
substantial insight into how the kidney handles salt in both health and disease.

Public health relevance
Project Narrative Problems with salt excretion by the kidney play central roles in several human diseases, including heart failure and hypertension. High potassium diets reduce blood pressure, by increasing salt excretion, and we will determine how this effect occurs. Conversely, consuming beverages that are high in fructose can lead to hypertension, and we will determine the mechanism by which sugar activates salt retention by the kidney.